PROPERTIES OF LYMPHOID TUMOR CELLS IN VIVO AND IN VITRO

Transplantable lymphoma cells, called reticulum cell sarcomas (RCS), from SJL mice induce strong proliferative responses and lymphokine production in syngeneic Lyl[unreadable]+[unreadable] 2[unreadable]-[unreadable] T cells but not in T cells from F[unreadable]1[unreadable] hybrid mice of SJL with strains expressing I-E. Thymus and lymph node cells from bone marrow chimeras of nonresponder F[unreadable]1[unreadable] into SJL respond as well as do SJL T cells and, conversely, T cells from SJL to F[unreadable]1[unreadable] chimeras fail to respond. It has been established that RCS cells do not express alien I-E-alpha chains, and monoclonal antibody to I-A[unreadable]S[unreadable] completely blocks T cell stimulation by RCS. Two-dimensional gel electrophoresis of labeled surface I-A show acidic A-alpha chains or RCS cells absent from normal SJL spleen cells but at least partially present on LPS-induced B-cell blasts. The molecular heterogeneity with respect to charge but not size is removed by treatment with neuraminidase, whereas tunicamycin-treated RCS and SJL spleen cell I-A molecules appear identical. Neuraminidase treatment enhances, while tunicamycin treatment abolishes, the ability of RCS to stimulate syngeneic T cells. Recently derived RCS-specific T cell clones respond to both RCS cells and to LPS-induced B cell blasts, but not to resting spleen cells from SJL or (SJL x BALB/c) F[unreadable]1[unreadable] hybrids and not to allogeneic (H2[unreadable]b[unreadable]) B cell blasts. The results to date suggest that the T cells which are stimulated by RCS, and whose response appears needed for RCS growth in vivo, are specific for activated B cell antigens, possibly glycosylated I-A molecules. These T cells may represent physiologically important autoreactive helper cells which, in SJL mice, are deregulated and promote growth of lymphomas of the B cell lineage. (LB)